A therapeutic workplace for homeless adults with alcohol use disorders

Alcohol addiction is as a chronic relapsing disorder. High magnitude and long-duration voucher-based
abstinence reinforcement is one of the most effective treatments for alcohol and drug addiction and can
maintain abstinence over extended periods of time, but practical methods of implementing these interventions
are needed. Workplaces could be ideal and practical vehicles for arranging and maintaining abstinence
reinforcement over long time periods. Our research on a model Therapeutic Workplace has shown that
employment-based abstinence reinforcement, in which participants must provide alcohol- or drug-free urine
samples to maintain maximum pay, can maintain alcohol and drug abstinence. Now we need to develop
effective and economically sound methods to arrange long-term exposure to employment-based abstinence
reinforcement. We are proposing to evaluate the effectiveness and economic benefits of a Wage Supplement
Model of arranging long-term exposure to employment-based abstinence reinforcement. Under this model,
successful Therapeutic Workplace participants are offered abstinence-contingent wage supplements if they
obtain and maintain competitive employment. Governments have used wage supplements effectively to
increase employment in welfare recipients. The Wage Supplement Model harnesses the power of wage
supplements to promote employment, while simultaneously using the wage supplements to reinforce alcohol
abstinence. The intervention will combine 3 elements -- the Therapeutic Workplace, Individual Placement and
Support (IPS) supported employment, and abstinence-contingent wage supplements. IPS is a supported
employment intervention that has been proven effective in promoting employment in adults with severe mental
illness. Under this model, participants will be exposed to the Therapeutic Workplace to initiate alcohol
abstinence and establish job skills. To promote employment and prevent relapse to alcohol use, participants
will receive IPS Plus Abstinence-Contingent Wage Supplements. A randomized trial will evaluate the
effectiveness and economic benefits of the Abstinence-Contingent Wage Supplement Model in promoting
employment and sustaining alcohol abstinence in homeless adults with alcohol use disorder (N=130).
Participants will be enrolled in the Therapeutic Workplace for 3 months and then randomly assigned to a Usual
Care Control group or an IPS Plus Abstinence-Contingent Wage Supplement group for one year. Usual Care
Control participants will be offered counseling and referrals to employment and treatment programs. IPS Plus
Abstinence-Contingent Wage Supplement participants will receive the IPS intervention and abstinence-
contingent wage supplements. Throughout the study, a wearable alcohol biosensor will be used to continuously
monitor alcohol use. This novel intervention could be an effective and economically sound way to promote
long-term alcohol abstinence and employment in homeless adults with alcohol use disorder, a population at risk
for many adverse outcomes because of their poverty, unemployment, homelessness and alcohol use.

Public health relevance
PROJECT NARRATIVE To address chronic alcohol addiction, this project will evaluate the effectiveness and economic benefits of abstinence-contingent wage supplements in the long-term treatment of homeless adults with alcohol use disorder. Participants will be offered wage supplements for maintaining competitive employment, but they will be required to abstain from alcohol use to maintain the maximum value of wage supplements. This novel intervention could be an effective and economically sound means of promoting long-term alcohol abstinence and employment and reducing poverty and homelessness in homeless adults with alcohol use disorder.